Center for Neural Circuits in Addiction

PROJECT SUMMARY: Overall
The NIDA Center for Neural Circuits in Addiction at the University of Minnesota (UMN) develops and
disseminates new technologies in the study of neural circuits to produce groundbreaking work in addiction
neuroscience. The Center comprises four Research Cores: 1) The Viral Innovation Core (VIC) assists
investigators in applying state-of-the-art viral manipulation approaches to their studies of the anatomical,
molecular and neural circuit bases of addiction providing expertise for design of custom vectors; 2) The Structural
Circuits Core (SCC) offers state-of-the-art anatomical mapping of neural circuits involved in addiction. Integrated
with the University Imaging Center and UMN Informatics Institute, SCC provides automated use of brain clearing
technology paired with meso- and micro-scale imaging of the CNS; 3) The Addiction Neural Dynamics Core
(ANDC) offers a range of imaging and electrophysiology modalities to monitor brain activity in behaving animals
across a range of spatial and temporal scales including: novel wide field-of-view optical imaging during behavior
at both the mesoscopic and cellular levels, fiber photometry, Neuropixel probes, new optical sensors, and
neuroengineering services for custom applications. 4) The Addiction Connectome Core (ACC) is collecting and
sharing an “addiction connectome” based on structural and functional connectivity Magnetic Resonance Imaging
(MRI) data in rodents and non-human primates over the addiction cycle and creating a computational platform
to integrate functional and structural data to test relationships between drug exposure and neural connectivity.
Our goal is for the Center to be a national resource for neural circuit research technologies that fuels high-impact,
collaborative research to address critical knowledge gaps in our field. The renewal specific aims for the Center
are: Aim 1. Maintain the framework and vitality of each Center Core. Provide: a) Education and training in new
technologies, b) Access to tools, reagents and expertise for data collection and analysis, c) Further development
and adoption of new technologies, d) Catalysis of new collaborations among users and e) Dissemination of
resulting research and new technologies to the wider addiction research community. Aim 2. Expand innovation
and service in our Research Cores. The Center's four Research Cores have each described additional innovative
tools under development with Center resources. While Center productivity has been strong in our first funding
period, the availability of new, state-of-the-art technologies to offer Center Investigators should continue to boost
the productivity and impact of neural circuit research in addiction at UMN.

Public health relevance
PROJECT NARRATIVE: Overall Addiction is a chronic relapsing brain disorder, and understanding how the brain can go awry will speed the design of more effective therapies. The University of Minnesota has thriving communities of both NIDA-supported addiction researchers and biomedical technology innovators. By bringing these communities together, our Center for Neural Circuits in Addiction drives innovative, high-impact research at the local and national level to help curtail this growing health problem.